Real-time detection of deviations in clinical care in ICU data streams

DESCRIPTION (provided by applicant): Timely detection of severe patient conditions or concerning events and their mitigation remains an important problem in clinical practice. This is especially true in the critically ill patient. Typical computer-based detection methods developed for this purpose rely on the use of clinical knowledge, such as expert-derived rules, that are incorporated into monitoring and alerting systems. However, it is often time-consuming, costly, and difficult to extract and implement such knowledge in existing monitoring systems. The research work in this proposal offers computational, rather than expert-based, solutions that build alert systems from data stored in patient data repositories, such as electronic medical records. Briefly, our approach uses advanced machine learning algorithms to identify unusual clinical management patterns in individual patients, relative to patterns associated with comparable patients, and raises an alert signaling this discrepancy. Our previous studies provide support that such deviations indicate clinically important events at false alert rates belo 50%, which is very promising. We propose to further improve the new methodology, and build a real-time monitoring and alerting system integrated with production electronic medical records. We propose an evaluation of the system using physicians' assessment of alerts raised by our real-time system for intensive-care unit (ICU) patient cases. The project investigators comprise a multidisciplinary team with expertise in critical care medicine, computer science, biomedical informatics, statistical machine learning, knowledge based systems, and clinical data repositories.

Public health relevance
PUBLIC HEALTH RELEVANCE: There remain numerous opportunities to reduce medical errors in the intensive care unit (ICU). This project develops and evaluates a new clinical monitoring and alerting framework that uses electronic medical records and machine-learning methods to send alerts concerning clinical decisions in the ICU that are unexpected given the clinical context and may represent medical errors.